Mechanisms Governing Activity-dependent Postnatal Brain Development

PROJECT SUMMARY
There is an urgent need to fully understand the fundamental mechanisms governing brain development
during the early postnatal period, a period that is critical in establishing the correct brain wiring for lifelong
behavioral and cognitive functions and a period during which, unsurprisingly, symptoms of many
neurodevelopmental disorders (NDDs) start to manifest. The functional maturation of the postnatal brain is highly
influenced by neuronal activity, but the mechanisms by which neuronal activity drives synaptic and circuit
maturation are poorly understood. It is particularly challenging to gain a whole brain view of the maturation
process because, in addition to the tremendous heterogeneity within the neuronal population, activity-dependent
maturation is highly variable across the brain, with different regions undergoing maturation at different times and
speeds. To meet this challenge, we have developed a genetic tool to capture the neuronal populations as they
undergo activity-dependent circuit maturation. With this tool combined with tissue clearing and whole brain
volume imaging, we propose to construct, for the first time, a spatiotemporal map of postnatal whole brain circuit
maturation. We will also examine the whole brain impact of developmental interventions, paving the way to
creating a discovery platform to study NDDs. Finally, taking advantage of our ability to distinguish neurons that
have undergone activity-dependent maturation from their less mature counterparts, we propose to uncover
molecular mechanisms underlying activity-dependent brain development. Our proposed research will provide
much-needed knowledge of postnatal brain development, and ultimately inform the design of future therapeutic
interventions to ameliorate symptoms of NDDs.

Public health relevance
Significance and Health Relevance of Proposed Studies The research described in this proposal will provide much-needed knowledge of postnatal brain development, and ultimately inform the design of future developmental interventions to ameliorate symptoms of neurological disorders.